Development of an effective, low-cost, point-of-care early detection test for oral cancer in low resource settings

ABSTRACT
Oral cavity and oropharyngeal squamous cell carcinoma (OOPSCC) affects 537,000 people worldwide
each year resulting in 313,000 reported deaths. These cancers continue to increase in incidence. The main risk
factors for OOPSCC include use of tobacco, alcohol, and betel nut in Southeast Asia, and oncogenic human
papillomavirus (HPV). Lower socio-demographic index regions exhibit the highest mortality rates for this
disease. OOPSCC usually presents with advanced local or regional disease when 5-year survival rates only
reach 30-40%. Thus, there is a significant, unmet need for improved detection of OOPSCC. as cure rates could
reach 90% if detected earlier. A low-cost, noninvasive, point-of-care (POC) test would improve time to OOPSCC
diagnosis and reduce the morbidity and mortality of this horrible disease. Our group invented patented
technology combining three biomarkers for OOPSCC including the stem cancer cell marker CD44, total protein
(TP), and p16 to develop an oral rinse early detection test. The test has been improved further by adding p16INK4a
(p16). Our preliminary data on 149 subjects using a POC prototype for the 3 markers and a machine learning
algorithm incorporating risk and demographic variables yields a sensitivity of 80% and specificity of 89%. To
advance this technology further in Specific Aim 1 we will develop CD44, TP and p16 point of care prototypes
into commercializable test strips. Vigilant Laboratories will work with DCN Dx, an engineering and diagnostics
contract manufacturer, to optimize the test strips for readability and reproducibility and use with DCN's reader
system which will provide quantitative outputs for each marker. Oral rinses collected from OOPSCC cases and
controls obtained from the University of Miami (UM) and University of California, San Diego (UCSD) will be used
to fine tune individual test strips. In Specific Aim 2 we will develop an OOPSCC risk model using the triple
biomarker test combined with risk factor and demographic data. We will use archived and prospective
samples from 250 cases and 500 controls (50 cases and 100 controls from UCSD). Risk factors such as age,
gender, tobacco, alcohol and oral health are recorded. In Specific Aim 3 we will test the comprehensive
OOPSCC risk assessment model in cases and matched controls. The model in Aim 2 will be frozen and
the algorithm from Aim 2 will be programmed into the reader which will display the final risk level for each tested
sample. Data will be collected prospectively from 75 cases and 175 controls (25 cases and 50 controls from
UCSD) in clinical settings at UM and UCSD using DCN's customized reader with incorporated algorithm.
Successful completion of these aims will result in a risk stratification system for patients at high risk for
OOPSCC with the next step being a Phase IIB multi-institutional trial for FDA PMA regulatory approval.

Public health relevance
PROJECT NARRATIVE Oral and oropharyngeal squamous cell carcinoma (OOPSCC) is a debilitating and deadly disease affecting over 537,000 people worldwide each year resulting in 313,000 reported deaths. Lower socio-demographic index regions exhibit the highest mortality rates due to OOPSCC. A low-cost, early detection test for oral cancer is needed, particularly in low resource settings to help diagnose this disease earlier and improve outcomes.